International Training in Environmental Health over the Lifespan

Project Summary / Abstract
Inadequate community inclusion in academic research and policy-making perpetuates the disproportionate
health impacts of climate change. Academic-community partnerships called "communiversities" are models
that have been used effectively to address environmental injustices. The communiversity model aims to
improve experts' and leaders' understanding of community-based participatory research (CBPR) to improve
public health. This supplement funding application will build on an existing partnership between the Icahn
School of Medicine at Mount Sinai located in New York and the National University in Costa Rica to support
training in CBPR approaches to climate change and health. The proposal focuses on two NIH Climate Change
and Health Strategic Framework Pillars: Health Equity, and Training and Capacity Building. This supplement
aims to create additional research training possibilities on climate change's effects on human health for
community leaders interacting with public university researchers in Costa Rica. We'll do this by sponsoring two
initiatives that fit well within the parent grant's aims:1) To add a course on CBPR methods for community
leaders and research scientists to the current "Virtual School for Latin American Public Health Professionals".
This course will consist of 14 modules based on the Third and Fourth National Climate Assessment's Health
Chapters, which organize climate change's health implications. These topics will be complemented with
modules on CBPR methods specifically designed for community leaders and academic scientists, respectively.
Specific aim 2) To support Mentored Communiversity Projects to Address the Health Effects of Climate
Change in Vulnerable Communities. After a call for applications, two projects that include partnerships
between community-based organizations and researchers from public universities will be selected for funding
and mentorship. We expect that these supplemental activities will result in seven community leaders and
seven researchers who will have participated in a course on CBPR and climate change, the development of
course materials that can be disseminated, and two communiversity projects that will have been implemented
with the potential to further address health effects of climate change in underserved communities in Costa
Rica.

Public health relevance
Project Narrative Climate change has been recognized as one of the most pressing problems of our time and it is projected to have an immense impact on human health, especially in developing countries such as Costa Rica. This administrative supplement will build on an existing research training program in environmental medicine by adding a component specifically focused on community-based participatory research on the effects of climate change on health. This addition to a successful research training program will support community-university partnerships to address the health effects of climate change on particularly vulnerable populations.